Nebraska Research Network in Functional Genomics

UNMC Administrative Core Project Summary The Administrative Core for the Nebraska IDeA Networks of Biomedical Research Excellence (NE-INBRE) is under the leadership of the Program Director/Principal Investigator (PD/PI), Dr. Jim Turpen, and includes Program Coordinator (PC), Dr. Bill Chaney, and the Grants Protocol Associate (GPA), Saralyn Fisher. The Administrative Core provides logistical support for all activities throughout the network. Moreover, the Administrative Core is responsible for the management, staffing, resource allocation and administering the award in compliance with National Institute of Health (NIH) policies, as well as for developing the programs that will meet the training and mentoring needs of students and faculty at the network PUIs. Among other entities the PI receives guidance from the Steering Committee, Senior Executive Committee, and External Advisory Committee to provide insight for the most effective way of implementing new programs as well as for conflict resolution. Likewise, working together with the Bioinformatics Core, the Administrative Core will facilitate electronic networking with NE-INBRE institutions and advise them of opportunities and modern technologies available at the Multiuser Core Facilities located at the RIs.

Public health relevance
Overall Project Narrative The “Nebraska Research Network in Functional Genomics, NE-INBRE, is designed to increase the biomedical research and training capacity at institutions of higher education and contribute to the development of the scientific workforce in the state. Primarily undergraduate institutions receive funding to enhance their faculty research and establish modern laboratories, thus providing opportunities for undergraduate students to engage in modern research and consider entering career in research and or the health professions. Research universities receive funding to support the development of multiuser core facilities that make cutting edge technology available to research programs on these campuses.